Regulation of upstream open reading frames in mRNA stability and translation

PROJECT SUMMARY
Upstream open reading frames (uORFs) play important roles in gene expression regulation and are associated
with numerous human diseases. Translated uORFs serve two major inhibitory functions: one is reducing
mRNA stability, presumably through nonsense-mediated mRNA decay (NMD), and the other is repressing the
translation of the downstream main ORFs (mORFs), both leading to decreased protein levels. Despite their
significance, our understanding of uORF regulation remains limited. To understand the mechanisms of uORF
regulation, we will combine high-throughput sequencing, molecular biology, bioinformatics, and machine-
learning models to identify and characterize uORF features and regulation using the tractable model
Arabidopsis, which enables in vivo and whole-organism level studies. In the next five years, we will address
three important questions about uORFs: (1) Does NMD control uORF-containing mRNAs? Through systematic
profiling of translated uORFs, we have made surprising discoveries: NMD appears not to regulate most
Arabidopsis uORF mRNAs, even though Arabidopsis uORFs repress mORF translation and reduce protein
levels like in other eukaryotes. This unexpected finding raises the possibility that plant uORFs either
systematically escape NMD, or trigger NMD but are compensated through alternative mechanisms. Addressing
this question is important because aberrant mRNAs in various human diseases evade NMD via unknown
mechanisms. (2) How do certain mRNAs overcome uORF repression through 'reinitiation' after uORF
translation? Reinitiation is poorly understood due to the lack of a robust in vivo system. A key regulator of
reinitiation in Arabidopsis is TARGET OF RAPAMYCIN (TOR), a conserved master regulator of translation and
growth. In Arabidopsis, activated TOR leads to the phosphorylation of translation initiation factor eIF3h,
promoting the reinitiation of several uORF-containing mRNAs crucial for development and metabolism. We will
leverage this TOR-mediated eIF3h phosphorylation system to study genome-wide reinitiation in vivo at the
whole-organism level and connect it to potential cis- and trans-regulation. (3) What uORF features control its
regulation in mRNA decay, translational repression, and reinitiation? We will integrate the genome-scale
datasets generated in this study with machine-learning models to quantify uORF characteristics influencing
protein production at multiple levels. Collectively, this research will enable us to 1) determine the relationship
between uORF translation and NMD, 2) investigate genome-wide reinitiation regulated by TOR-mediated
eIF3h phosphorylation, and 3) identify which uORF features impact mRNA stability and translation. This work
will provide a comprehensive understanding of the dual regulation of uORFs. Our long-term vision is to develop
Arabidopsis as a model system to identify both the divergent and conserved principles governing gene
regulation through uORFs and provide insights into potential innovative therapies for human health.

Public health relevance
PROJECT NARRATIVE Upstream open reading frames (uORFs) are associated with numerous diseases, as they regulate mRNA stability and translation. This study investigates uORF features and functions involved in mRNA decay and translation controlled by evolutionarily conserved regulators using a model system that enables in vivo and whole-organism level studies. Our findings could open doors to innovative diagnosis and treatment strategies.